Novel therapies for obesity- or diabetes-related lymphatic dysfunction

Abstract: Endothelial dysfunction such as lymphatic dysfunction (LD) affects many patients in the U.S.
According to a report of the NIH, LD is one of the most poorly understood, relatively underestimated, and least
researched complications of diseases or its treatment in the U.S. Secondary LD is caused by an endothelial
dysfunction or an acquired defect in the lymphatic system and is commonly associated with obesity, diabetes,
infection, neoplasm, trauma, and therapeutic modalities. Although not reported as often as postmastectomy-
induced LD, obesity is also one of the most common causes of LD seen in practice in the U.S. today. In the
U.S., over 20% of the population (~40 millions) is considered obese. The prevalence of LD in general obese
population is relative low; however, an estimated 74% prevalence of LD in morbidly obese patients has been
reported. LD is one comorbid condition that has not been well studied in morbidly obese patients, whose
population has been increasing year after year. LD may also be associated with intravenous drug abuse. If not
properly managed, LD can lead to painful limb swelling, chronic inflammation, tissue fibrosis, and increased
susceptibility to serious infection and other diseases. Thus, there is an unmet yet urgent medical need to
establish novel anti-LD therapeutics for reducing or overcoming the debilitating effects of LD in the expanding
population of LD patients with morbid obesity or diabetes. This research is proposed to tackle this poorly
addressed problem. The rationale is based on our findings demonstrating that hormone—adrenomedullin
(ADM)—and its cognate receptors, the calcitonin receptor-like receptor (CLR) and receptor activity-modifying
proteins (RAMPs), are required for lymphatic vessel development and are necessary and sufficient to
reprogram adult tissue stem cells to generate functional lymphatic endothelial cells (LECs). LECs can form
new lymphatic vessels to restore lymphatic circulation in LD patients suffering from LD. Wild-type ADM has an
extremely short half-life in vivo, limiting its clinical application. Notably, ADM(22–52) functions as a potent
ADM-receptor (CLR/RAMP2) antagonist (termed AMRA) for blocking vascular angiogenesis and tumor growth.
Thus, we propose creating highly stable proprietary albumin (Alb)-ADM and Fc-ADM fusion proteins as clinical
anti-LD therapeutics and Alb-AMRA and Fc-AMRA as proprietary nontoxic anti-angiogenesis/antitumor protein
drugs. Specific Aims: (Aim 1) Generate a panel of Alb-ADM and Fc-ADM fusion proteins, characterize the
most active fusion proteins using in vitro and in vivo assays, and create Alb-AMRA and Fc-AMRA proteins
similarly. (Aim 2) Assess the efficacy and specificity for lymphatic regeneration with combined regimens of Alb-
ADM plus Alb-AMRA or Fc-ADM plus Fc-AMRA in the murine models of hindlimb LD, and conduct their toxicity
studies in vivo. Significance: After this study, we will identify potent anti-LD regimens ready for preclinical
development (e.g., toxicity studies and pharmacokinetics), which will be addressed during Phase II. This work
strongly supports Phase II, making this work a compelling and first-in-class anti-LD therapy.

Public health relevance
Project Narrative Lymphatic dysfunction (LD) is one of the most poorly understood, relatively underestimated, and least researched complications of diseases or its treatment in the U.S. We have identified a novel approach, using a stable version of an engineered peptide hormone, to increase normal lymphatic regeneration specifically and alleviate LD. This novel therapy has the potential to decrease the debilitating and painful effects of the progression of LD among patients with serious endothelial dysfunction and thus have a high impact on helping those diseases survivors with despairing LD. We expect this work strongly supports Phase II to make this work to be an effective, worthy, and first-in-class therapy for this poorly addressed disease.